APOLIPOPROTEIN C III/ CII NORMOLIPEMIC HYPERTRIGLYCERIDEMIA

Using stable isotope infusions of amino acids, rates of synthesis and fractional catabolic rates of apolipoprotein CII and CIII will be estimated in patients with hypertriglyceridemia and normals on a high fat diet.